Regulation of cellular plasticity and regeneration in Drosophila spermatogenesis

Abstract
Adult tissues typically rely on self-renewing stem cells to sustain tissue homeostasis. In
response to injury, however, additional cells can be recruited to participate in
regeneration, or the regrowth of lost tissues or organs. Understanding regeneration is a
longstanding goal in biology. Cells that can adopt the biological properties of other cell
types under specific conditions, or possess cellular plasticity, are key contributors to
regeneration, but their regulation is poorly understood. By developing the Drosophila
testis as a model system to study the biology of stem cells and their microenvironments,
or niches, we have discovered unexpected cellular plasticity among the constituent cell
types. Advantages of this system include the relative simplicity of the tissue and an
unparalleled collection of genetic tools with which to probe it functionally. Our ability to
genetically manipulate cells in vivo and then determine the effects on stem cell function
has led to several foundational discoveries. Previously, we showed that damaging the
Drosophila testis causes differentiating germ cells to dedifferentiate, becoming new
germline stem cells that can repair the tissue. We also found that quiescent somatic
niche cells can transdifferentiate into new somatic stem cells upon tissue damage.
Here we combine live imaging, lineage tracing, and results from our recent single cell
transcriptomic profiling of this tissue to determine how niches sense damage and then
activate program(s) to regenerate missing stem cells. We also characterize candidate
signals that relay information from stem cells back to their niche. Finally, we investigate
the role of newly identified genes that could function in organism-wide communication
with the niche. Our synergistic approach will enhance the understanding of the
fundamental cellular and molecular mechanisms regulating stem cell renewal in the
testis, which has important implications for understanding male fertility and
regeneration.

Public health relevance
NARRATIVE This work will contribute significantly to what is known about the mechanisms promoting regeneration in living adult animals. By using complimentary genetic, molecular and live imaging approaches in the Drosophila testis, we will identify the cellular and molecular mechanisms that enable tissues to sense damage and then activate a program to regenerate missing stem cells. These mechanisms are of strong general interest, as they will suggest successful therapeutic strategies for achieving healthy tissue regeneration.